Novel Small Molecule Drug Candidate for the Prevention of Bronchopulmonary Dysplasia

PROJECT SUMMARY/ABSTRACT
CMTx Biotech is a drug development company working to commercialize a proprietary, clinical-stage, small-
molecule drug candidate for the prevention of respiratory distress syndrome (RDS) and its long-term sequelae,
bronchopulmonary dysplasia (BPD), in preterm infants. BPD is a chronic respiratory disease that occurs in
preterm infants who develop RDS from a combination of lung immaturity, inflammation, and mechanical injury
from ventilation. BPD is the most common adverse outcome of preterm delivery, affecting up to 75% of infants
born before 28 weeks of gestation worldwide. Every year in the U.S., approximately 380,000 of these infants
are born, of which 50,000 are extremely low gestational age newborns (ELGANs), 35% (18,000) of which
develop BPD. The median cost of hospitalization associated with BPD during the first year in very low birth
weight infants is $377,871 per infant, compared to $175,836 per infant without BPD. There are currently no
FDA-approved drugs specifically for the prevention and treatment of BPD. The current standard of care is
focused on minimizing lung damage and providing respiratory support with the use of bronchodilators,
diuretics, antibiotics, surfactant, and steroids, including antenatal steroid treatment of the mother before
preterm birth. Most agents that are prescribed to prevent BPD are also used for the management of
established BPD, and these therapies lack solid evidence of efficacy. A recent clinical study concluded that
hydrocortisone is not effective at preventing BPD in premature infants or improving their survival. There
remains a critical unmet need for safe and effective therapeutics for the prevention of BPD. Our lead
drug candidate is a pleiotropic matrix metalloproteinase (MMP) modulator which inhibits pathologically-
excessive collagenolysis and resolves systemic inflammation. Safety of the compound has already been
demonstrated in Investigational New Drug (IND)-enabling studies. The drug has been evaluated in a number of
clinical trials for the treatment of diseases as disparate as AIDS-related Kaposi’s sarcoma, recurrent high-
grade gliomas, refractory metastatic cancer, acne, rosacea and periodontitis. The Specific Aims of this STTR
are to determine the ability of our lead drug candidate to prevent the onset of BPD in a preterm piglet model,
and to evaluate its effect on the pathogenesis of BPD and inflammatory pathways. Our long-term goal is to
obtain approval from the FDA and comparable international regulatory authorities to market our drug candidate
as a safe and effective intervention. We anticipate that our drug candidate will inhibit BPD progression, mitigate
acute lung injury and respiratory distress, reduce the need for intensive care and intubation, and improve
clinical outcomes for pre-term infants, including overall survival. Successful completion of these studies will
allow CMTx Biotech to advance our lead drug candidate towards clinical trials for the prevention of BPD.

Public health relevance
PUBLIC HEALTH STATEMENT / PROJECT NARRATIVE Bronchopulmonary Dysplasia (BPD) is a chronic respiratory disease that occurs in preterm infants who develop Respiratory Distress Syndrome (RDS) from a combination of lung immaturity, inflammation, and mechanical injury from ventilation. Infants with BPD often have substantial long-term respiratory and neurodevelopmental morbidities, in addition to increased likelihood of re-hospitalization, asthma, and chest wall deformities. This proposed project is directly relevant to the public health, since it is to develop a promising drug candidate for the treatment of this critical unmet medical need.